Measuring retinal ganglion cell spike responses in the intact perfused eye following optic nerve injury

PROJECT SUMMARY
Injuries to the optic nerve damage or sever the axons of retinal ganglion cells (RGCs), leading to vision loss that
is currently irreversible. While optic nerve regeneration in a major research area, little is known about the early
functional changes to RGCs that precede cell death. Strategies to restore vision, as well as improved diagnostics,
require more detailed information about the time course of changes in RGC spike responses after optic nerve
injury.
I propose to address this knowledge gap by developing a new preparation of the intact mouse eye and its
supporting vasculature. We are working to adapt an isolated, perfused eye preparation that has been published
in larger eyes, into the mouse while simultaneously using high-density electrodes to record spikes from the optic
nerve. Aim 1 will validate the successful functional identification of RGCs using opto-tagging. Aim 2 will measure
the time course of dysfunction in identified RGCs following optic nerve cut while experimentally varying the
location of the cut along the nerve.
The successful completion of this project will establish a new preparation with advantages over existing
preparations for studies of the earliest RGC dysfunction in retinal disease.

Public health relevance
PROJECT NARRATIVE Optic nerve injuries often lead to the degeneration of retinal ganglion cells causing irreversible blindness. While the late stages of degeneration, in which retinal cells die, are well studied, much less is known about the earliest signs of retinal dysfunction following these injuries. We are developing a new preparation of the intact, perfused mouse eye where, for the first time, we will be able to make chronic recordings of retinal ganglion cells for hours to days after optic nerve cut and map the earliest changes in their light responses.